Targeting anti-viral and anti-inflammatory responses during ocular HSV-1 infection to prevent vision impairment.

Project Summary
The corneal transparency is essential for normal vision. However, the recurrent episodes of herpes simplex
virus-1 (HSV-1) infection of the cornea causes stromal keratitis (SK), a very painful and vision impairing
chronic inflammatory disease. SK is a severe condition and the leading cause of infectious blindness in the
US. The virus replication in the corneal epithelium and associated inflammation play a central role in SK
progression. Current SK therapies such as corticosteroids and anti-virals are non-specific, partially effective,
and cause severe ocular and systemic side effects. Therefore, there is an unmet need to develop novel
immunotherapies to address deficiencies associated with current SK therapies. The selective induction of a
potent anti-viral state with minimal activation of inflammatory immune responses embodies a powerful means
to treat patients with recurrent chronic SK pathology. In this application, we propose one such approach
targeting IL-27, an immunoregulatory cytokine, to induce endogenous anti-viral and anti-inflammatory
responses after corneal HSV-1 infection to suppress SK progression. Macrophages (Mϕs) play a central role
in HSV-1 clearance through phagocytosis of infected epithelial cells and apoptotic neutrophils. Our preliminary
data indicate that HSV-1 stimulates IL-27 production by Mϕs. Further, we show that IL-27 is critical for limiting
HSV-1 replication in the cornea, IFN-β production, optimum induction of adaptive immune responses, and
suppression of SK pathology. Moreover, we show that HSV-1 promotes Mϕ metabolic reprogramming with
significantly increased immune-responsive gene 1 (Irg1) expression. Irg1 is an enzyme that converts citrate
to itaconate during the tricarboxylic acid (TCA) cycle. Itaconate is a mitochondrial metabolite produced by
activated Mϕs to regulate inflammatory and anti-viral responses. Our data show that IL-27 negatively
regulates Irg1 expression in Mϕs after HSV-1 infection. Thus, our central hypothesis is that IL-27 plays a dual
anti-viral and anti-inflammatory role in SK progression through modulation of HSV-1-induced increased
Irg1/itaconate metabolism in Mϕs to promote type I IFNs-mediated protective responses. In this proposal, we
will investigate the molecular mechanisms for IL-27-mediated immunoregulation of innate and adaptive
immune responses during SK progression (Aim1) and elucidate the interplay of HSV-1-induced IL-27 and
Irg1/itaconate metabolism in Mϕs and role in SK progression (Aim 2). The successful completion of proposed
studies will identify novel molecular mechanisms for HSV-1-induced Mϕ metabolic reprogramming and the
contribution of Mϕ-specific IL-27/Irg-1/itaconate in the induction of anti-viral versus inflammatory responses
during SK. These studies will open the platform for developing novel, safe, and effective therapies targeting
IL-27 and Mϕ metabolism to suppress recurrent HSV-1 infection and SK progression.

Public health relevance
Project Narrative The recurrence of herpes simplex virus-1 (HSV-1) at the ocular surface causes stromal keratitis (SK), a leading cause of infectious blindness in the US. The main goal of this project is to simultaneously enhance anti-viral and anti-inflammatory responses during ocular HSV-1 infection by targeting the endogenous immunoregulatory IL-27 pathway. The information gained from these studies will identify novel targets to develop new treatment approaches for patients suffering from recurrent episodes of SK.